Asymmetric Reactions with Dual-Functional Organocatalysis

DESCRIPTION (provided by applicant): During the last two funding cycles our research program has made significant progress in the development of asymmetric base catalysis, as well as acid-base and iminium-base bifunctional catalysis by organic catalysts as broadly applicable concepts for the development of asymmetric reactions. In our previous studies the catalysts afford activity, enantioselectivity and diastereoselectivity through their involvement in a single transition state of stereochemical consequences. Our proposed studies focus on the invention and development of new reaction cascades. Building on preliminary results revealing the ability of cinchona alkaloids to serve as efficient chiral proton donors, the development of asymmetric dual-functional cooperative organocatalysis becomes a common theme underlying our proposed studies. In this mode of catalysis the organic catalysts act as a bifunctional catalyst to promote two different individual steps in the reaction cascades by activating and orienting the two participating reactants or intermediates. The specific aims are: 1) Development of enantioselective and diastereoselective conjugate addition-protonation reactions of ???-disubstituted nitroalkenes for asymmetric synthesis of chiral amino compounds. 2) Development of biomimetic proton transfer catalysis for enantioselective isomerizations of ???-unsaturated carbonyl to chiral ???-unsaturated carbonyl compounds via tandem deprotonation-protonation reactions. 3) Development of asymmetric peroxidations via enantioselective and chemo-controlled conjugate addition-protonation reactions with hydroperoxides. By establishing a broad range of synthetically important asymmetric transformations that currently represent unmet challenges for existing catalysts, our studies will provide unique entries into and achieve efficient asymmetric syntheses of chiral molecules of biological and therapeutic interest that are either inaccessible or difficult to prepare in a concise and useful manner by existing synthetic methods.

Public health relevance
PUBLIC HEALTH RELEVANCE: Small molecules constitute one of the most important forms of therapeutic agents and play an increasingly important role in biomedical research. The goal of this work is to develop new and efficient synthetic methods that will greatly enhance our ability to rapidly create molecules of diverse structures with defined configuration, thereby providing biomedical researchers with powerful tools to accelerate the discovery of small molecules possessing biologically interesting and therapeutically desirable properties. These synthetic methods will also provide the foundation for the development of cost-effective processes for the sustainable manufacturing of therapeutic agents with significant implications to public health.